High Sensitivity In Vivo Imaging System with Integrated Micro-Computed Tomography for Animal Phenotyping Core

PROJECT SUMMARY.
High-sensitivity and microscale resolution instruments are essential for groundbreaking biomedical research. In
vivo imaging technologies are particularly valuable to measure complex biological processes in live animals and
track them over time, such as cancer metastasis, volume distribution of novel drugs and tissue homing of stem
cells after transplantation. Optical imaging, in particular, has become extremely sensitive with the development
of very efficient fluorescent dyes and nanoparticles as well as luciferase-based bioluminescence tools. In vivo
spatial targeting of optical signals through the development of transgenic animals and cells that are engineered
to express fluorescent or bioluminescent reporters, in both inducible and conditional manners, have enabled
unprecedented in vivo applications of optical imaging in a variety of research fields. This shared instrumentation
proposal is to purchase the optical IVIS SpectrumCT system (PerkinElmer), which will operate within the
Metabolic Phenotypic and IVIS Core (Animal Phenotyping Core) in the Boston University Medical Campus. This
Core has been successfully operational since 2011 and currently offers technical support for this instrument to
18 NIH-funded principal investigators. A variety of groundbreaking research projects has been conducted with
the use of the Animal Phenotyping Core’s IVIS over the years, including the development of novel cargo
nanoparticles for drug delivery, the discovery of molecular targets of cancer progression and metastasis, the
optimization of tissue homing and organ regeneration with pluripotent stem cells. The new SpectrumCT is a
high-sensitivity optical imaging platform with integrated micro-computed tomography for 2D and 3D
bioluminescence and fluorescence detection and radiographic (CT) imaging. This state-of-the-art instrument will
replace our current IVIS, which is no longer supported by PerkinElmer, while providing enhanced capabilities for
monitoring and quantifying biological processes longitudinally in up to 10 live animals. This new generation IVIS
provides fast multi-imaging modality combined with low dose CT, enabling co-registration and spectral unmixing
for advanced 2D analysis and 3D reconstructions. In addition to ongoing projects, the new IVIS SpectrumCT will
be used by additional NIH-funded users to advance their research on bone development, the effect of obesity
on breast cancer, novel antibiotic therapeutics and other groundbreaking research projects. Importantly, the
availability of this in vivo instrumentation will complement ex vivo imaging and quantitative modalities, such as
confocal microscopy and FACS, currently available in the core facilities across the entire Boston University
community, expanding the high-end instrumentation toolset crucial for the success of research investigators.

Public health relevance
PROJECT NARRATIVE. Instruments with high sensitivity and microscale resolution are crucial for biomedical scientific discoveries; in vivo imaging is particularly valuable to measure complex biological processes in live animals. This shared instrumentation grant will provide the Metabolic Phenotyping and IVIS Core at Boston University Medical Campus with a fluorescence/bioluminescence optical in vivo system with integrated computed tomography (IVIS SpectrumCT; PerkinElmer). This state-of-the art instrument will allow our investigators to perform groundbreaking research on cancer progression and metastasis, bone development, nanoparticles for drug delivery, organ regeneration with pluripotent stem cells and many more research areas, for the advancement of science and the development of new therapies.